Engineering Polymers to Scavenge DAMPs in Arthritis and Lupus

Abstract/Statement of Work
Previous studies from our laboratories have indicated that nucleic acid binding polymers (NABPs), also
termed nuclear acid scavengers (NASs), can inhibit immune responses induced by nucleic acids in
both acute and chronic models in lupus prone mice. While these studies indicate the potential utility of
NASs as a therapy for lupus, many aspects of their pharmacologic properties are less than ideal.
Therefore, to advance this novel approach, we will utilize cutting edge bioengineering strategies to
create novel, biocompatible NABPs for in vivo use as nucleic acid scavengers. Finally, the proposed
research will incorporate studies with lupus patient material as well as animal models to address
fundamental issues on nucleic acid DAMP (Damage Associated Molecular Pattern) responses, identify
novel biomarkers for disease progression and classification and elucidate the mechanism(s) by which
NABPs sequester and scavenge nucleic acids to prevent (or disrupt) the formation of immune
complexes and thereby reduce the pathogenic potential of such DAMPs. Three specific aims are
proposed:
Aim #1: To rationally engineer biocompatible, nucleic acid scavengers with optimized binding to
nucleic acid-containing DAMPs and associated DAMP complexes.
Aim #2: To evaluate the therapeutic efficacy, safety, biodistribution and biocompatibility of
soluble and nanoparticle containing nucleic acid scavengers in mouse models of lupus
that display renal, cutaneous and arthritic manifestations.
Aim #3: To elucidate the mechanism(s) by which nucleic acid scavengers counteract the ability
of nucleic acid-containing DAMPs to activate inflammatory cells in mice and in patient
samples.
Successful completion of the studies proposed will set the stage for the clinical development of a novel
class of safe and potent anti-inflammatory agents for lupus and lupus-arthritis patients.

Public health relevance
Project Narrative Engineering Polymers to Scavenge DAMPs in Lupus and Lupus Arthritis Dead and dying cells release nucleic acids. These extracellular RNAs and DNAs can be recognized as Damage Associated Molecular Patterns (DAMPs) and taken up by inflammatory cells and activate multiple nucleic acid- ‐sensing Toll- ‐Like Receptors (TLR3, 7, 8 and 9) and other pattern recognition receptors (PRRs). The inappropriate activation of these TLRs and PRRs can engender a variety of inflammatory and autoimmune diseases including systemic lupus erythematosus (SLE) and rheumatoid arthritis (RA). The redundancy of the nucleic acid- ‐sensing TLR/PRR family suggests that biomaterials that can neutralize the proinflammatory effects of any nucleic acid regardless of its sequence, structure or chemistry would be useful anti- ‐inflammatory agents. We have preformed preliminary studies indicating that such “nucleic acid scavengers” can reduce inflammation in animal models of SLE and RA. Herein we propose to explore in detail this novel approach to anti- ‐inflammatory drug design. We will evaluate the ability of this approach to limit lupus and lupus arthritis patient samples from activating of innate inflammatory cells in vitro and employ biomedical engineering to create potent and safe agents to scavenge nucleic acid- ‐containing in animal models. We will test the therapeutic efficacy of such agents in a murine model of SLE and Lupus Arthritis. Successful completion of these studies will yield a novel, safer strategy as well as lead therapeutic agents to treat SLE and other inflammatory diseases that afflict millions of Americans and patients throughout the world. Thus these studies are greatly needed and highly clinically significant.